RESEARCH IN STATISTICS

This project addresses statistical problems generated from collaboration with scientists in other program areas and general statistical problems of current interest encountered in biomedical research. This work is a continuing activity of the Branch. In FY99, Branch statisticians have contributed to the following areas of statistical research: statistical screening for diseases in populations; measurement of structural uncertainties in morbidity due to the choice of disease definition; investigation of selection bias in epidemiological surveys; application of time series to longitudinal imaging of the developing brain in heathly individuals and patients with neurological diseases; establishment of reference range values for diagnostics tests; development and application of nonparametric regressions for the analysis of neuroimaging data; the application of recursive partitioning for the evaluation of risk factors in epidemiological studies; and the development of mixture models for clinical time series. Other active areas of statistical research are: the development of nonlinear response models for nondecreasing and time-dependent response functions from multiple compartments; statistical modeling of longitudinal data to identify bench mark events and their time of occurrence in the clinical course of disease; adapting analysis methods for the estimating the level of disease risk for individual factors in the presence of many correlated potential risk factors; the formulation of analysis methods for survival data with time dependent covariates, and new likelihood ratio tests for logistic mixture models in time series. - Statistical methods, neuroimaging, epidemiology, time series, survival analysis, surveys - Human Subjects & Human Subjects: Interview, Questionaires, or Surveys Only